Disentangling the roles of endoplasmic reticulum stress and activity in the peripheral olfactory circuit

PROJECT SUMMARY
Olfactory dysfunction is a frequent sign of insidious neurological disease, likely due to the delicate molecular
mechanisms required to maintain a functioning sense of smell. Olfactory sensory neurons stochastically express
a single odorant receptor gene out of ~1000 in the mouse. The expressed odorant receptor then specifically
drives olfactory neuron axons to a unique and stereotyped position in the olfactory bulb called a glomerulus,
forming a spatial map of glomeruli which each represent just one odorant receptor. The molecular mechanism
that pairs odorant receptor identity with glomerular target has remained disputed. Several experiments have
shown that neuronal activity can elicit major changes in the transcription of axon guidance molecules. More
recently, studies from our lab have implicated endoplasmic reticulum stress signaling as the critical variable for
proper glomerular targeting. Interestingly, several genes that are upregulated by neuronal activity are
downregulated by endoplasmic reticulum stress, and vice-versa. We are proposing to systematically disentangle
the effects of endoplasmic reticulum stress and olfactory sensory neuron activity at different timepoints across
the lifetime of olfactory neurons. We first aim to test the effects of endoplasmic reticulum stress on axon guidance
programs in immature olfactory sensory neurons. Next, we aim to uncover the molecular mechanism(s) that are
responsible for the inverse effects of endoplasmic reticulum stress and neuronal activity on gene expression.
Finally, we propose to test the effects of endoplasmic reticulum stress on synaptic function in mature olfactory
sensory neurons. Our findings could have broad implications for the development and maintenance of
neurological circuits, beyond the olfactory system.

Public health relevance
PROJECT NARRATIVE Cells in the brain and nervous system develop using a variety of signaling cues, including stress and activity. The effects of these two mechanisms are intertwined in olfactory neurons, the cells in the nose responsible for smell (a sense that is often affected in patients with neurological diseases). We are proposing to disentangle the roles of these two signals across different stages of the olfactory neuron lifespan.